Genomics Core

PROJECT SUMMARY (See instructions): Our overall Program is focused on understanding the oncogenomic changes in myeloma central to disease pathogenesis which impact clinical outcome. We have proposed two large clinical trials; first to evaluate the role of transplant in the era of novel therapies; and second to evaluate progression from MGUS/SMM to active MM, which will accrue 1000 patients and 1210 patients, respectively, both in France and the United States. A critical aspect of obtaining robust ongenomic data is to have centralized and uniform processing and analysis of samples with established SOPs. Specifically, samples will be obtained from patients enrolled on the randomized trial evaluating lenalidomide bortezomib and dexamethasone (RVD) with or without high dose therapy and autotransplant at time of diagnosis (Project 2) and at relapse (Project 4); and from patients with monoclonal gammopathy of undetermined significance/smoldering MM (MGUS/SMM) at time of study entry and progression (Project 2). In each case, tumor cells versus normal cells will be isolated in Core B using well established procedures. Core C will perform DNA, RNA, and microRNA analyses on these samples. In addition, this Core will perform genomic analyses on preclinical samples, specifically evaluating changes in RNA and miRNA resulting from gain and loss of gene function, as well as before and after novel targeted therapies. This Core will provide a detailed catalog of gains or losses in DNA by using Genome Wide Human SNP 6.0 array. Levels of mRNA expression and splicing of all genes will be assessed using whole transcript GeneChip¿ Human Exon 1.0 ST array. Micro RNA (miRNA) profile will be established using qPCR-based miRNA arrays. This core has also interacted closely with investigators in Core E for bioinformatic support and data analysis, which is essential for the success of our proposed studies. This core has and will continue to help identify novel targets and validate targeted therapies in preclinical studies in Project 3. The following 3 Specific Aims will be pursued: to assess changes in DNA by high density SNP array analysis (Specific Aim 1); to evaluate expression profile and alternate splicing using Exon 1.0 ST array (Specific Aim 2); to profile miRNA using high density qPCR array (Specific Aim 3). Core C is therefore an essential and integral component to meet our goals.

Public health relevance
RELEVANCE (See instructions): The mission of this Core is to provide data on genomic changes in clinical and preclinical samples using a standardized approach.